Identifying urinary biomarkers for early type 2 diabetic nephropathy

DESCRIPTION (provided by applicant): Candidate: Maryam Afkarian received an MD-PhD from Washington University in St. Louis and underwent residency training in Internal Medicine at New York Presbyterian Hospital-Weill Cornell Medical Center. She is currently a Nephrology Research Fellow at the joint program of Massachusetts General Hospital and Brigham and Women's Hospital. Starting July 2010, she will be appointed as an instructor at the Nephrology Division of Massachusetts General Hospital. Mentor: Dr. Ravi Thadhani is an internationally recognized clinical and translational investigator with a strong track record of mentoring new investigators. He is, and will remain, a closely-involved mentor, committed to the success of Dr. Afkarian's training, her proposed studies and career development. Research: Diabetic nephropathy (DN) is the leading cause of end-stage kidney disease. However, with the current standards of care, we can only delay progression of this disease. This is partly due to a lack of effective therapies and partly due to absence of reliable assays for diagnosis of the early disease, before renal damage is severe or irreversible. New diagnostic and therapeutic tools are urgently needed, both of which require an improved understanding of the disease natural history, i.e. identification of new markers of onset and progression. Comparative proteomic analysis of urine (study of the urine protein composition and how it is changed in the disease state) has been used to identify markers for several kidney diseases. Dr. Thadhani (mentor)'s group has previously used this approach to identify a peptide signature that detected signs of early diabetic kidney injury up to 10 years prior to clinical diagnosis. This proposal lays out a multi-stage approach to identify the proteins that are altered in early DN. The preliminary data describes calibration and adaptation of a sensitive proteomic technology (iTRAQ: isobaric Tags for Relative and Absolute Quantitation) for application to urine. In Aim 1A, iTRAQ will be used to compare urine samples from patients with and without DN (cases and controls, respectively). This hypothesis-free and unbiased comparative analysis will generate a preliminary list of candidate biomarkers for early DN. In Aim 1B, this list will be supplemented with hypothesis-driven candidates, i.e. those with significant evidence of involvement in DN. Examples are proteins which (a) are part of pathways incriminated in DN, (b) have altered mRNA expression in DN or (c) have altered protein level in DN. This step serves to incorporate all currently available information into this biomarker discovery effort. In Aim 3, a target-specific and quantitative assay, e.g. ELISA, is used to re-evaluate the expression of putative biomarkers from Aims 1A and 1B in an independent cohort. This step will help weed out the false positives and identify a subset of markers whose differential expression in DN is confirmed. In Aim 4, the expression of these confirmed markers will be characterized over the course of disease. This proposal is designed to generate a group of candidate biomarkers for early DN which have been validated within the original study population. A future step would be to test these candidates in a broader and more varied population. In long term, we hope that the validated biomarkers would serve as a novel diagnostic tool for early DN and also help shed light on the disease pathophysiology.

Public health relevance
PUBLIC HEALTH RELEVANCE: Diabetes is the leading cause of end-stage kidney disease and dialysis in the US. The current medical tests can diagnose the disease only after significant and sometimes irreversible damage has already occurred. We plan to find urine marker proteins that can be used to detect early signs of diabetic damage to the kidneys, when it is more likely to be stopped or reversed. PROJECT NARRATIVE Diabetes is the leading cause of end-stage kidney disease and dialysis in the US. The current medical tests can diagnose the disease only after significant and sometimes irreversible damage has already occurred. We plan to find urine marker proteins that can be used to detect early signs of diabetic damage to the kidneys, when it is more likely to be stopped or reversed. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Development of effective diagnostic and therapeutic tools for diabetic nephropathy requires identification of new markers of onset and progression. Microalbuminuria, our best currently available marker, confers a 2-4 fold greater risk of progression to overt proteinuria and diabetic nephropathy [1]. However, it does not clearly distinguish reversible from irreversible stages of disease [2-4], and its absence does not necessarily indicate absence of disease [2, 4-6]. Identification of early markers of impending nephropathy is necessary for earlier diagnosis as well as development and testing of new therapies. Proteomic analysis of urine has been applied to biomarker discovery in type 2 diabetic nephropathy [7- 12]. However, these studies have a few limitations. They have mostly used a cross-sectional approach where albuminuric samples are used as cases and normoalbuminuria is equated with absence of disease. In addition, many have not used subsequent post-proteomic analyses to validate putative markers. Our group has identified a peptide signature predicting diabetic nephropathy up to 10 years prior to albuminuria. Using mass spectrometry (SELDI-TOF: Surface-Enhanced Desorption/Ionization Time-Of-Flight Mass Spectrometry), we analyzed urine samples collected prior to microalbuminuria in a longitudinal study of type 2 diabetes and identified a peptide signature that predicted development of diabetic nephropathy up to 10 years before it was clinically diagnosed [13]. This observation suggested two points. First, that there are quantifiable changes in the urine protein composition, even in early stages of diabetic nephropathy, i.e. years before onset of microalbuminuria. Secondly, that these changes are detectable by mass spectrometry. We now propose to use early urine samples from the same population to identify the proteins whose urinary concentration is altered in early diabetic nephropathy. We propose a multi-stage experimental design, outlined in the following Specific Aims (Figure 1): Aim 1A. Generation of a panel of unbiased diabetic nephropathy candidate biomarkers: We will use mass spectrometry to compare early disease urine samples from 80 diabetic subjects who develop nephropathy 10 years later (cases) with 80 matched diabetic subjects who retain normal renal function after >10 years of follow-up (controls). Cases and controls will be matched for sex, age, race, BMI, HbA1C, blood pressure and duration of diabetes. Our proteomic tool is iTRAQ (isobaric Tags for Relative and Absolute Quantitation) a broad-based and sensitive mass spectrometric technology [14-16] which we have specifically adapted and calibrated for use in urine. Aim 1B. Supplementation of the candidate panel with hypothesis-driven candidates: We will supplement the preliminary candidate list from Aim 1A with specific candidates derived from: i. biological pathways with substantial evidence of involvement in diabetic nephropathy, ii. proteins whose involvement in diabetic nephropathy is supported by two or more of the following: ¿ comparative expression arrays of diabetic nephropathy ¿ comparative proteomic analysis of diabetic nephropathy ¿ candidate gene association Aim 2. Quantitative analysis of the preliminary biomarkers: This step will serve to eliminate the false positives and validate the differential expression of putative biomarkers in an independent group of cases and controls. For this step, we will use highly quantitative assays such as Multiple Reaction Monitoring/Stable isotope dilution (MRM/SID-MS) [17, 18] or immunoaffinity-based assays (e.g. ELISA) to evaluate expression of candidates from Aims 1A & B in 50 cases and 50 controls defined and matched as in Aim1A. Aim 3. Characterizing expression of confirmed candidates over the course of disease: The urinary levels of the confirmed candidates from Aim 2 will be measured in samples collected at 2-year intervals from baseline to the end of 10-year follow-up. This will establish the pattern of marker expression over time and help populate the pre-albuminuria disease course with markers of onset and progression. Our approach differs from those of previous studies in a number of key ways: 1. Use of samples from longitudinal studies: Assignment of case vs. control status based on cross- sectional clinical data (i.e. presence or absence of proteinuria at one time-point) has multiple disadvantages. First, in the cross-sectional approach, cases are diabetics with current renal failure or proteinuria. However, markers found at these late stages of disease are likely to represent plasma proteins leaking into the urine through damaged glomeruli. As such, these proteins are more likely to follow, rather than precede, renal failure or proteinuria. To identify biomarkers of early diabetic nephropathy, we will use urine samples from longitudinal cohorts, i.e. urine that is collected before the onset of microalbuminuria, from patients with historically proven diabetic nephropathy. Secondly, the cross-sectional approach defines controls as diabetics with current or recent normo- albuminuria. However, these diabetics may have undiagnosed early diabetic nephropathy. Using samples from longitudinal studies avoids this problem by definitively ascertaining control phenotype after >10 years of observed normo-albuminuria and normal kidney function. 2. Combining broad-based and candidate-specific approaches: This proposal combines the breath of an unbiased proteomic approach with specificity of a hypothesis-driven targeted approach to generate a comprehensive panel of candidate biomarkers for early diabetic nephropathy. 3. Phased experimental design: We use a phased design consisting of successive analytic platforms with complementary strengths to maximize power while minimizing precious resources [18]. 4. A sensitive mass spectrometric technology specifically adapted to urine: We use a sensitive mass spectrometry technology that reduces random variation by allowing simultaneous analysis of case and control samples in the same experiment [14-16] (Figure 2). We have further calibrated and adapted this technology for application to urine (see section C.3.).